Administrative supplement: Multi-cuvette spectrofluorometer for studying multicomponent mechanochemical regulation of actin dynamics

This document is not a requirement for this submission.

Public health relevance
This document is not a requirement for this submission.